Applying Machine Learning in the Prediction and Identification of Children Affected by Prenatal Alcohol Exposure

Project summary
Fetal alcohol spectrum disorders (FASD), which are caused by prenatal alcohol exposure, occur in up to 5% of
the population in the United States, and are associated with lifelong disability. There are multiple difficulties in
obtaining an accurate diagnosis of FASD, including subtlety of physical features and heterogeneity in
presentation. Consequently, FASD is grossly under-recognized, and the majority of affected children never
receive a diagnosis. If FASD could be diagnosed earlier and with more reliability, many years of beneficial
intervention would not be lost.
The objective of this research is to apply machine learning to high-dimensional data in well-characterized data
sets to predict or characterize children with FASD. The central hypothesis of this research is that the
application of machine learning will accurately predict and recognize FASD compared with expert clinical
diagnosis. To test this hypothesis, machine learning will be employed to: 1) characterize FASD based on the
presence of non-cardinal malformations, 2) establish multivariate predictors of FASD in preschool aged
children, and 3) identify diagnosis specific neurodevelopmental markers that distinguish alcohol related
neurodevelopmental deficits from neurodevelopmental deficits without prenatal exposure. Two secondary data
sources will be used in this proposal; a prospective study of 400 pregnant women and their offspring in
Ukraine (half of whom consumed high amounts of alcohol) with full clinical evaluations for FASD, and a cross-
sectional study of over 2,900 first grade children in four regions of the U.S., all with clinical FASD evaluations.
Upon successful completion of the proposed research, the expected contribution is for more accurate
prediction and recognition of children with FASD. The proposed research is innovative, as it represents a
departure from current practice by incorporating machine learning techniques into predictive models of FASD.
As a perinatal epidemiologist, I have a strong foundation in analytic techniques, and the advanced training in
machine learning will further enhance these skills. Additionally, the disease-focused training in dysmorphology
and neurodevelopment will provide a strong foundation to make significant contributions to the field of FASD
research. Finally, training and mentoring in grant writing and the responsible conduct of research will provide
a strong foundation to transition to an independent researcher. This proposed research builds on previous
NIAAA funded research by my interdisciplinary mentoring team, who are all strongly supportive of this
research and training plan.
This seminal application of machine learning to FASD research will demonstrate its capacity to predict and
identify affected children, ultimately leading to earlier intervention of children prenatally exposed to alcohol.

Public health relevance
Narrative Fetal alcohol spectrum disorders (FASD) are common and result in lifelong disabilities; however, they are clini- cally difficult to identify, and the vast majority of children with FASD are undiagnosed or misdiagnosed. The proposed research will leverage recent advances in machine learning to better identify children with FASD. These advances would lead to earlier identification and intervention in the lives of children prenatally exposed to alcohol, which can improve their developmental outcomes.